Brainstem Contributions to Sensorimotor and Core Symptoms in Children with Autism Spectrum Disorder

PROJECT SUMMARY/ABSTRACT The brainstem is a complex and early-developing brain region that is responsible for sensory, motor, autonomic, and critical-for-life functions. The first biology-based hypothesis of autism spectrum disorder (ASD) suggested that the reticular formation of the brainstem may be a root cause of ASD symptoms. However, technological barriers have prevented the field from being able to reliably characterize substructures of the brainstem in vivo in children. Excitingly, new technological advances now allow us to examine the microstructural properties of the brainstem's nuclei and individual white matter tracts. The overall scientific premise of this proposal is that brainstem substructures may hold key insights into overall brain development and into the underpinnings of ASD. The overall objective of the proposed work is to identify specific white matter tracts and nuclei within the brainstem that subserve the comorbid sensorimotor and core symptom challenges of ASD and to contextualize brainstem properties in reference to other brain regions implicated in ASD. Given the functions of the brainstem, we hypothesize that the microstructural properties of the brainstem substructures are associated with comorbid sensorimotor symptoms and core social-communication and repetitive-behavior symptoms implicated in ASD. We further hypothesize that the brainstem relates distinctly to other brain regions in ASD, due to the brainstem's role in early brain development. Guided by strong preliminary data, these hypotheses will be tested through three specific aims: 1) Determine extent to which the microstructure of brainstem substructures is associated with individual differences in comorbid sensorimotor symptoms; 2) Determine extent to which microstructure of brainstem substructures is associated with individual differences in core social-communication and repetitive- behavior symptoms; and 3) Identify the distinct correspondence among brainstem substructures and the surrounding brain. A key innovation is that we will accomplish these aims by applying a diffusion-weighted imaging (DWI) technique that addresses the previous challenges of brainstem imaging to provide a clear and anatomically precise image of the brainstem and its substructures. With this technique, we will quantify the microstructure of brainstem substructures (and surrounding brain) in 80 children with ASD (6-9 years old) and 80 age-matched children with typical development. Standardized assessments will characterize sensorimotor and core symptom profiles. The successful completion of this research will provide a quantitative characterization of brainstem substructures in relation to the comorbid sensorimotor features and core symptoms in ASD, and it will provide a quantitative characterization of brainstem substructures in ASD in relation to overall brain metrics. These contributions will be significant because they will advance the understanding of the neurobiological basis for ASD, elucidate the neurological underpinnings of the comorbid sensorimotor challenges and core symptoms in ASD, and provide quantitative biomarkers to be used as outcome measures in clinical trials.

Public health relevance
PROJECT NARRATIVE The prevalence and impact of ASD is widely known, but the brain basis of ASD remains unclear. The proposed research will solve an urgent public health need to provide a more complete depiction of early-developing brainstem structures in relation to the core and comorbid symptoms of ASD. This brainstem characterization will further provide potential biomarkers, which can subsequently be used to evaluate treatment progress and to develop new, targeted interventions. Therefore, the proposed work is in line with NIH's mission to acquire new knowledge that will help reduce the burden of human disability. The proposed work is also in line with the NICHD's priorities to understand the complexity of comorbid symptoms in developmental disabilities like ASD and to develop valid biomarkers.